Mechanisms of developmental buffering

PROJECT SUMMARY/ABSTRACT:
The long-term objective of this proposal is to understand genetic buffering, or how some individuals overcome
the effects of a harmful genetic mutation. We generated a zebrafish model of buffering in order to understand
how individuals who should have gotten sick are somehow able to live unaffected healthy lives. In our model,
we used selective breeding to generate two strains of zebrafish that develop dramatically different head
skeletons in response to the same harmful genetic mutation. In one strain, the mutation causes severe, lethal
skeletal defects. Meanwhile, the other strain is remarkably buffered against the mutation. The buffered fish
develop essentially normal head skeletons, surviving to be fertile, viable adults. We compare these strains to
understand the natural buffering mechanisms that are present in some fish, and likely in some humans too. We
hypothesize that buffering is due to factors that tune developmental processes to restore balance. For
example, in Aim1 we will determine how DNA sequences which oppose the mutant gene can be turned down.
In Aim 2 we examine how factors encoded in the DNA which perform the same function as the mutant gene
can be turned up. In Aim 3 we will determine how changes that do not necessarily involve alterations in the
DNA sequence can buffer the harmful mutation. These three specific aims test how interacting mechanisms
function together to buffer development. We designed experiments to address these aims using state of the art
methods like genome editing and sequencing, colorful cell and tissue labeling, quantitative measurements of
large numbers of fish skeletons, and rigorous statistical analyses. The mechanisms we propose to study here
are present in many developmental systems and organisms and therefore will likely be applicable in wide-
ranging settings. This study of buffering mechanisms could lead to novel therapeutic approaches, buffering
mechanisms might be manipulated in the future to manage disease symptoms. This work will also lead to a
better understanding of the factors that make predicting genetic disease from gene sequences difficult. Thus,
this line of research will potentially inform and improve medical practices, including genetic disease
management, disease diagnosis, and counseling, falling squarely within the mission of the NIDCR to improve
dental, oral and craniofacial health through research.

Public health relevance
PROJECT NARRATIVE Human health relevance: Some humans inherit a harmful genetic mutation, yet they somehow buffer the effects of the mutation and do not show signs of genetic disease. We generated a zebrafish model of buffering to understand how some individuals who should have gotten sick are able to live normal healthy lives. Understanding the naturally occurring mechanisms of buffering is the first step toward new therapeutic strategies capitalizing on innate protective mechanisms in some individuals.